Low-cost mobile colposcopy and confocal imaging for global prevention of cervical cancer

Abstract:
Cervical cancer was once the leading cause of cancer death among women in the United States (U.S.).
The implementation of comprehensive programs for screening, diagnosis, and treatment over the past 60
years has reduced cervical cancer incidence and mortality by more than 70% in the U.S. In contrast, cervical
cancer remains the 1st or 2nd leading cause of cancer death among women in many low-and middle-income
countries (LMICs). Cervical cancer prevention programs in low-resource settings are hampered by a lack of
personnel with appropriate clinical expertise, lack of pathology services, and lack of associated infrastructure.
Programs that involve multiple patient visits have a high rate of loss to follow-up. Screen-and-Treat
approaches have been implemented in LMICs and include screening by HPV testing or visual inspection with
acetic acid (VIA) followed by immediate treatment, reducing loss to follow-up; but these approaches lead to
massive over-treatment due to the poor specificity of VIA and HPV testing. There is an urgent need for
appropriate diagnostic tools to enable the implementation of a sensitive and specific Screen-Diagnose-Treat
strategy that can be performed in a single patient visit in LMICs and in medically underserved areas of the U.S.
We propose to develop and validate a low-cost Multimodal Mobile Colposcope (MMC) for global cervical
Screen-Diagnose-Treat programs. This new device will combine the imaging capabilities of a smartphone-
based colposcope developed by MobileODT with the microscopic imaging capabilities of a fiber-optic confocal
imaging probe developed by Rice University. The MMC will image the entire cervix, automatically identify
suspicious regions, and acquire co-registered high-resolution images of nuclear morphometry from suspicious
areas. Multimodal image analysis algorithms will be developed in a study of 300 women referred for
colposcopy at two sites in Brazil. The performance of the MMC with automated image analysis for detection of
cervical precancer will be validated in a study of an additional 760 women referred for colposcopy in Brazil.
We will determine the feasibility and usability of the MMC among low-resource setting providers by carrying out
cancer prevention training courses using the MMC in Brazil.
Our academic-industrial partnership includes expertise in bioengineering (Rice University), colposcopy and
medical imaging (MobileODT), cervical cancer prevention and treatment (MD Anderson Cancer Center), and
cervical cancer prevention and epidemiology (Albert Einstein College of Medicine), as well as the clinical
expertise of our Brazilian clinical partners: Barretos Cancer Hospital and the Federal University of Health
Sciences of Porto Alegre/Hospital Santa Casa. The innovative imaging technologies to be developed in this
proposal will enable effective single-visit Screen-Diagnose-Treat programs to diagnose and treat women with
cervical precancer while minimizing overtreatment.

Public health relevance
Project Narrative / Public Health Relevance Statement: Cervical cancer is a major global health problem. Globally, 570,000 new cases of cervical cancer occur annually, resulting in 311,000 deaths, nearly 90% of which occur in low- and middle-income countries (LMICs). There is a critical need for a sensitive and specific Screen-Diagnose-Treat strategy that can be performed in a single visit in LMICs as well as low-resource settings in the US to reduce the morbidity and mortality of this disease.